ENDOMETRIAL ANTIGENS INVOLVED IN ENDOMETRIOSIS

Women's health problems, especially endometriosis, are of top priority. Isolation of specific endometrial antigens eliciting autoimmunity in endometriosis is the desired goal, so that an endometrial antigen-specific antibody assay can be developed for a non-invasive diagnosis and monitoring of endometriosis In women of all races and from all areas in U.S.A.. The research goals are: (1) To elute antigens specifically binding to serum or peritoneal fluid IgG in patients with endometriosis, from the native and cultured endometria / endometriosis implants. (2) To isolate the antigens of interest using polyclonal antibodies. (3) To use the polyclonal and monoclonal antibodies to isolate sufficient quantities of these antigens to develop a specific endometrial antibody assay for the clinical diagnosis and management of endometriosis.